Developmental prosopagnosia subtypes: validation, neural mechanisms, and differential approaches to treatment

The goal of this proposal is to better characterize the cognitive and neural basis of face perception
heterogeneity in developmental prosopagnosia (DP) and to test whether potential perceptual subtypes are
better suited for one type of cognitive training program vs. another. This is relevant to the National Eye
Institute's mission to better treat visual disorders and understand mechanisms of visual function. Our pilot
results (N=45 DPs) provide preliminary evidence that there are perceptually-impaired (PI-DPs) and
perceptually-unimpaired (PU-DPs) DP subgroups that may be mechanistically distinct. We find that PI-DPs
have deficient eye processing, reduced holistic processing abilities, reduced N170 response to eye contrast-
reversed faces, and a trend towards decreased white matter integrity in the occipital face area, a face-selective
region involved in face parts processing. We also find that PI-DPs, compared to PU-DPs, show a greater
treatment response to our computerized face perception training program. The goals of the current proposal
are to build on these pilot results to further test and validate the PI-DP vs. PU-DP subgroup distinction, to
better understand the neural mechanisms underlying perceptual heterogeneity in DPs, and to examine
treatment implications of potential subgroups. In particular, our aims for this proposal are to: 1) Collect a large
sample of web-based and in-lab DPs (N=280) and controls (N=140) and replicate our pilot findings showing
eye processing and holistic processing deficits in PI-DPs. We will also perform latent profile analysis to
determine if DPs naturally form PI-DP vs. PU-DP subgroups or rather represent a continuum of face
perception deficits. 2) Characterize the neural mechanisms of DP face perception heterogeneity using
functional fMRI, EEG, and diffusion tensor imaging in 80 DPs and 40 controls. To test better understand the
neural underpinnings of DPs' reduced eye region sensitivity and reduced holistic processing, we seek examine
the N170 event-related potential response to isolated eyes vs. mouths as well as face inversion and for fMRI,
population receptive fields of face-selective regions as well as responses to isolated mouths and eyes. We will
also examine whether PI-DPs vs. PU-DPs have white matter integrity differences in face-selective white matter
regions. 3) Determine whether PI-DPs vs. PU-DPs have differential responses to face perception training, face
memory training, or face perception+face memory training programs. This will involve a longitudinal study of
120 DPs being assigned to either a waitlist control condition or 6 weeks of one of the three cognitive training
programs. Before and after training/waiting, we will assess DPs on a validated battery of face perception and
recognition tests as well as self-reported face recognition. To measure the longevity of potential training
effects, DPs will also repeat assessments after a 6-week no-contact period.

Public health relevance
Developmental prosopagnosia (DP), a disorder in which individuals have severe lifelong face recognition deficits, affects up to 2.5% of the population and currently has no treatment. We have found preliminary evidence of meaningful perceptually-impaired vs. perceptually-unimpaired DP subgroups and propose to further test and validate these subgroups in a large sample, examine the neural mechanisms of DP perceptual deficits, and also test whether DP subgroups differentially respond to cognitive training treatments targeting face perception vs. face memory. This could not only help developmental prosopagnosics but potentially other disorders with face processing deficits.